Administrative Core

Project Summary - Administrative Core
The Administrative Core of the Integrative Center for Environmental Microbiomes and Human Health COBRE
(ICEMHH) will be directed by Dr. Anthony Amend (Associate Professor, Pacific Biosciences Research Center
(PBRC)), with the day-to-day administrative activities of the core coordinated by Dr. Marilou Andres (Assistant
Researcher, PBRC). The principal function of the Administrative Core is to facilitate the effective and efficient
functioning of this COBRE at the University of Hawai’i at Manoa (UHM). This Core will oversee strengthening
and enhancement of the Center through the development, mentoring and graduating of the research project
leaders (RPLs). It will organize the meetings of the Administrative Core Team composed of project mentors,
core leaders, the executive committee and RPLs, and will facilitate the communication of all Center personnel.
It will also organize the twice-yearly meetings with the Advisory Committee (AC). The Administrative Core will
prepare progress reports and provide these to the AC and NIH, and serve as a dynamic link between this
COBRE and UHM, other UHM COBREs, and the UHM INBRE program, including assuming leadership of the
joint IDeA Mentoship Bootcamp. It will also be responsible for the full logistical and administrative support of
both the individual RPL projects and their supporting core facilities. Such efforts will include maintaining all
aspects of the budget, staff records, equipment inventories, and advice on manuscript preparation and support
for proposal submission. The Core will support a yearly meeting to bring in leaders in the field of microbiome
research to discuss their work and the intellectual context in which the Center is expanding. The Administrative
Core will additionally develop a data portal to help standardize and streamline Microbiome research and
outputs. Finally, this Core will be responsible for executing all evaluation, assessment and any corrective
actions for the COBRE.